FOLLOW-UP OF ACL REPAIR WITH MACINTOSH AUGMENTATION GRAFTING

Retrospective study of patients undergoing Anterior Cruciate Ligament Repair with MacIntosh Augmentation Grafting within three weeks of rupture to evaluate restoration of knee function and ability to prevent degenerative changes.